Identification of GP38 and NP antibodies and their protective mechanisms against CCHFV

Summary/Abstract
Crimean-Congo hemorrhagic fever virus (CCHFV) is a ssRNA (-) nairovirus that produces
fever, prostration, and severe hemorrhages in humans. Fatality rates typically associated with
CCHFV can be up to 40%. CCHFV has rapidly spread across large sections of Europe, Asia, and
Africa. Recently, CCHFV and its tick reservoir have illustrated their continued ability to spread into
previously naive regions. At the same time, U.S. citizen traffic has increased substantially to regions
endemic with CCHFV, specifically South-Central Asia and the Black Sea Region. As a result, there is
a substantial risk for transmission of CCHFV and/or its tick vector to the United States. CCHFV is not
the only nairovirus that threatens the public. Other nairoviruses to include Nairobi Sheep Disease and
Erve viruses as well as newly discovered members in Songling and Yezo viruses can cause human
disease of varying severity and economic distress. There is no vaccine or prophylactic currently
available for treatment of CCHF or any other nairovirus related disease. Recently studies have
identified that including a 38 KD non-structural glycoprotein protein of CCHFV (GP38) as a vaccine
antigen can confer a level of protection against CCHFV challenge. Also, targeting of CCHFV GP38
using non-neutralizing monoclonal antibodies (mAb) have been shown as a viable route to protective
post-exposure broad-spectrum (mAb) strategies that show more potential than their neutralizing
counterparts. Beyond GP38, examination of protection conferred by fast acting CCHFV viral replicon
particles has revealed that non-neutralizing humoral responses to CCHFV nairovirus nucleoprotein
(NP) are an important contributor to protection against these viruses. This proposal will reveal the
protective attributes of non-neutralizing mAbs targeting these two viral proteins, opening the door to
new routes of vaccine and therapeutic intervention for CCHFV and other related bunyaviruses. These
insights will then be used to isolate from CCHFV survivors mAb candidates for further pre-clinical and
clinical testing that are highly efficacious with broadly cross protective characteristics.

Public health relevance
Public Health Relevance Crimean-Congo hemorrhagic fever, Thunderclap headaches, and Nairobi sheep disease, are a small sampling of the dangerous emerging human and animal diseases caused by nairoviruses that can potentially cause widespread health and economic devastation. Recently, Crimean-Congo hemorrhagic fever virus encoded glycoprotein 38 (GP38) and nucleoprotein (NP) have been found to trigger protective non-neutralizing immune responses. This proposal serves to investigate and leverage this phenomenon through synergetic molecular, cell based and in vivo means to provide information for the development broad-based anti-viral treatments against Crimean-Congo hemorrhagic fever.